VASOPRESSIN AS A CRITICAL VARIABLE IN THE TREATMENT OF NOCTURNAL ENURESIS

The purpose of this study is to understand the hormone vasopressin, osmolality, and the relationship between functional bladder capacity and enuresis.